Transcriptional interference through LUTI mRNA expression in development

PROJECT SUMMARY
Cellular differentiation is driven by changes in gene expression. To transition from one
type of cell to another, cells must simultaneously activate genes that promote differentiation while
repressing genes that antagonize faithful progression. How gene repression is achieved amidst
widespread transcriptional activation is not fully understood. A recently described mode of gene
repression, which relies on integrated transcriptional and translational interference, exemplifies
the coordination of transcriptional activation and gene repression. In this form of gene regulation,
a long undecoded transcript isoform (LUTI) is transcribed from a gene-distal promoter, leading to
repressive co-transcriptional chromatin modifications over the gene-proximal promoter4, 6, 34. In
contrast to the efficiently translated, canonical transcript derived from the proximal promoter, the
LUTI contains upstream open reading frames in its 5’ extended sequence which prevent
translation of the protein coding sequence4, 5, 34.
First observed in budding yeast gametogenesis - the differentiation program required to
produce sex cells - and later during the yeast unfolded protein response and in human cells12, 36,
LUTI-based regulation allows cells to toggle between a repressive and coding transcript
throughout differentiation. Furthermore, LUTI-dependent interference over the proximal promoter
is tunable and reversible, permitting dynamic developmental gene expression. While the
chromatin modifications induced by LUTI transcription have been described, trans-acting factors
required for LUTI-dependent nucleosome positioning changes have yet to be uncovered. This
proposal seeks to uncover these factors using forward genetics in yeast and to characterize their
role in developmental gene regulation. Preliminary work from these approaches implicates the
Swi/Snf chromatin remodeling complex in LUTI-based transcriptional interference.
Experiments proposed in aim 1 will investigate the role of the Swi/Snf complex in LUTI-
based regulation during yeast gametogenesis, first by assaying regulation of the model LUTI gene
NDC80 and then on a global scale. Results from aim 2 will reveal whether the LUTI transcriptional
interference mechanism is conserved from yeast to humans. Aim 2 also seeks to uncover a
functional role for LUTI-based gene repression during differentiation of human embryonic stem
cells to the endoderm fate. Together, these experiments will illuminate the molecular requirements
for LUTI-based gene repression and functional significance of LUTI transcription in development.

Public health relevance
PROJECT NARRATIVE This proposal seeks to characterize the mechanism underlying a recently described form of gene regulation that integrates transcriptional and translational interference via expression of a class of noncanonical mRNAs known as long undecoded transcript isoforms (LUTIs). Dissecting this mechanism in two developmental contexts, Saccharomyces cerevisiae gametogenesis and human endoderm differentiation, will uncover novel roles for evolutionarily conserved chromatin remodeling factors and histone modifying enzymes. Investigation of LUTI-based regulation in human cells will also contribute to a deeper understanding of how transcriptional landscapes affect gene regulatory networks in early development and how their misregulation can lead to disease.